PEDIATRIC HOSPITALIZATION AND COMPETING PARENTAL DEMANDS

CORE LAB ONLY STUDY - The purposes of this study are to describe parents' management of competing demands (work, care of child's siblings or other dependent family members, self care), that continue while a child is hospitalized. The study will explore the relationship between parental visitation patterns and the child's response to hospitalization and describe outcomes for the child at 1 month post-discharge. The GCRC core laboratory does the analysis of salivary cortisol.